Unified Program for Therapeutics in Children

ABSTRACT
The pipeline for prophylactics and therapeutics that target pediatric diseases is sparse compared to that of adults.
A limited pool of pediatric physician-scientists knowledgeable in the myriad of factors that create this translational
divide compromises the development of promising therapies. The primary goal of the Unified Program for
Therapeutics in Children (UPTiC) has been to train early-career pediatric physician-scientists with strong
academic potential to lead the discovery and development of novel therapeutics and prophylactics for children
and be thought-leaders in the field of pediatric drug development. The program trains subspecialty pediatric
fellows in 3 tracks that span the full pipeline of drug development: 1) discovery-based research
(preclinical/translational pediatric drug development), 2) pediatric clinical trials and prospective cohort
studies, and 3) outcomes/real world evidence. The program covers three major training aims, including: 1)
individualized didactic and degree-oriented course work in pediatric drug development, 2) mentored training in
preclinical, clinical trials, and outcomes research, and 3) grant-writing training. The training of these pediatric
research fellows features a combined effort of the Duke University School of Medicine, including the Department
of Pediatrics and the Duke Clinical Research Institute, and the University of North Carolina at Chapel Hill,
including the Department of Pediatrics, School of Pharmacy, and School of Public Health. UPTiC is led by a
team of multi-institutional, multi-disciplinary, well-funded, and experienced faculty members, including 44 full-
time Duke and UNC faculty members in Pediatrics and other basic, translational, and clinical science
departments. This renewal application requests support for four postdoctoral pediatric trainees (two new fellows
per year, 2 years of support each). Trainees are drawn from the national pool of pediatric fellow applicants at
Duke and UNC through early engagement with fellow applicants and program directors and direct outreach to
pediatric research and clinical organizations. In its initial cycle, the program trained 17 pediatric subspecialty
“Katz-Denny” fellows who studied new therapeutic approaches including small molecules, biologics and devices,
sought new biomarkers, and discovered new biological underpinnings of diseases in children. Katz-Denny
fellows have been well-published, and the majority have obtained grant funding during and/or beyond the period
of training. As the program evolves, two primary goals for the next cycle include expanding cross-institutional
programming and research engagement across Duke and UNC, and enhancing programmatic
diversity. Fulfillment of the program's objectives will address two imperatives: 1) the need for more full-time
academic pediatric physician-researchers and mentors in medical schools throughout the country and 2) the
need for innovations, basic discoveries, and clinical translation of novel pediatric prevention and treatment
strategies to improve the health of the youngest and most vulnerable members of society.

Public health relevance
PROJECT NARRATIVE The pipeline for novel therapeutics for children is extremely limited compared to that of adults due to several aspects of therapeutic development for the pediatric population, including specific safety, regulatory and ethical concerns, the low incidence of many pediatric diseases, and age-dependent pharmacokinetic factors. Therefore, there remains a paramount need for pediatric physician-scientists who are knowledgeable in pediatric drug discovery, clinical trial design, and postmarketing evaluation. This renewal application for the Unified Program for Therapeutics in Children (UPTiC) will continue to train pediatric physician-scientists to lead the development, implementation, and evaluation of novel prophylactics and therapeutics for pediatric populations to improve the health and well-being of children.